Mechanistic bases of strain-specific virus-host interactions

Abstract
Influenza A viruses (IAVs) are responsible for seasonal flu and pose a pandemic threat. The overarching goal
of our research is to understand the structural and biophysical mechanisms at the molecular level by which
nonstructural protein 1 (NS1) of IAVs interferes with host antiviral responses. NS1 is a major virulence factor of
IAVs, counteracting host antiviral immune responses. Remarkably, NS1 has a multifaceted strategy to interfere
with many host proteins involved in viral RNA (vRNA) sensing and degradation, apoptosis, and interferon
production. Furthermore, NS1 is one of the most frequently mutating proteins in the IAV genome. Therefore,
studying the evolution of NS1 and its role in immune evasion and modulation is essential for understanding the
strain-specific virulence of IAVs. However, to understand the evolutionary development of NS1’s strain-specific
functions, it is necessary to examine the interactions between newly acquired mutations and other residues
within NS1, which are known as epistatic interactions. Addressing the molecular mechanisms of epistasis is a
major challenge in the fields of protein science and evolution. Over the next five years, we will investigate how
NS1 interferes with host immune responses in a strain-specific manner. In this proposed research, we will
address the questions of how epistatic interactions contribute to the strain-specific interactions between NS1
and host proteins, and how NS1 employs its RNA-binding ability to antagonize vRNA sensors that initiate
innate immune responses. To accomplish our goal, we will use an integrated approach including X-ray
crystallography, cryo-electron microscopy (EM), NMR and fluorescence spectroscopies, chemical crosslinking
using amber-codon suppression, molecular dynamics simulation, and cell-based experiments to parallel our
structural and biophysical studies. This research will provide a mechanistic framework for a quantitative
understanding of NS1's strain-specific immune evasion functions. As a result, this study is expected to have a
positive impact on the development of antiviral agents targeting NS1-host protein interactions.

Public health relevance
Project Narrative The proposed research is relevant to public health because the molecular mechanisms by which the influenza A virus evades the host immune system are expected to advance the development of antiviral therapeutics. The mechanisms underlying the strain-specific virulence of influenza A viruses are expected to enhance preparedness for future flu pandemics. Therefore, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will advance understanding of human health and disease.